RNA-Dependent Protein Assemblies in Epidermal Homeostasis

RNA-DEPENDENT PROTEIN ASSEMBLIES IN EPIDERMAL HOMEOSTASIS
Project Summary/Abstract
Dysfunction of epidermal homeostasis can result in a plethora of diseases, such as psoriasis, atopic dermatitis,
and skin cancer. The high incidence of skin diseases in about 25% of Americans highlights the need to expand
our understanding of epidermal homeostasis mechanisms. Previous studies have shown that RNA-binding
proteins (RBPs) are required to control keratinocyte proliferation and differentiation. However, how RBPs
organize and collaborate in cis on RNA molecules to form functional ribonucleic protein complexes (RNPs) and
how additional layers of regulation, such as post-translational modifications (PTMs), affect their roles in
epidermal homeostasis, is currently unexplored. To address this, I have developed, in collaboration with postdoc
fellow Dr. Brian Zarnegar, two new crosslinking immunoprecipitation (CLIP)-based methods, termed irCLIP-RNP
and Re-CLIP. Both methods leverage the infrared-coupled 3’biotin adapter modification of the original irCLIP
protocol to greatly enrich for RNA-dependent cis-RBP assemblies (irCLIP-RNP) and for RNA targets that are
simultaneously co-bound by two RBPs of interest (Re-CLIP). These approaches represent a unique framework
for studying RBP assembly code and its PTMs on co-bound RNA targets central to epidermal differentiation.
Thus, this K99/R00 application aims to characterize the roles of RBP assemblies in epidermal homeostasis.
In Aim I, we will test the model of RBP code in epidermal differentiation by comparing two RBPs, HNRNPC
and HNRNPU, which we found essential for progenitor maintenance. Preliminary irCLIP-RNP data indicates
distinct RBP codes for either HNRNPC or HNRNPU. Aim I.A will test the consequences of knocking out these
distinct RBPs on progenitor RNA lifecycles. Aim I.B will analyze the extent to which these distinct combinatorial
assemblies collaborate to affect the fate of co-bound RNA targets.
In Aim II, we will test the RBP assembly model in untranslated regions (UTRs) in epidermal functions and how
PTMs affect this process. Specifically, we will analyze the RBP code of TARDBP, a highly modified RBP, which
we found essential in regulating progenitor RNA expression by binding their 3’UTRs. Aim II.A will define the
identity, assembly dependencies, and functions of TARDBP and co-associated RBPs to regulate progenitor
RNAs through 3’UTR binding. Aim II.B will determine how the increased phosphorylation of TARDBP during
epidermal differentiation affects its functional recruitment on target RNA 3’UTRs.
My long-term goal is to lead an academic research group focused on skin homeostasis mechanisms. I aim to
study RNA-protein regulatory networks in epidermal differentiation, building on my expertise in RNA biology,
RBP biochemistry, and bioinformatics. While training at Stanford's Department of Dermatology, I plan to gain
new skills in machine learning, proteomics, genomics, and statistics. I will also participate in leadership and
management seminars. This comprehensive research and training plan, supported by my mentor and
collaborators, will provide me with a broad skillset crucial for a successful transition to independent investigator.

Public health relevance
RNA-DEPENDENT PROTEIN ASSEMBLIES IN EPIDERMAL HOMEOSTASIS Project Narrative Epithelial tissue maintenance relies on a complex interplay of regulatory factors that govern various cellular processes, ultimately balancing cell division, differentiation, and senescence. When this delicate regulatory system fails, it can result in skin disorders like psoriasis or cancer. This research proposal investigates the roles and mechanisms of RNA-dependent protein assembly dynamics and their post-translational modifications in shaping the RNA profile crucial for epidermal homeostasis.